Asymmetric Nucleophilic Aromatic Substitution Enabled by Hydrogen-Bonding Catalysis

Project Summary/Abstract
Stereogenic-at-phosphorus (P-chiral) P(V) compounds are an increasingly important motif in the design of life-
saving pharmaceuticals such as broad spectrum anti-viral medications (Remdesivir, Sofosbuvir, Tenofovir
Alafenamide) to treat hepatitis B and C as well as Ebola and COVID-19. Despite the enormous importance of being
able to introduce P-chiral centers into compounds to develop new medications to combat existing and emergent
diseases, access to this chemical motif remains constrained by a lack of efficient chemical methods. As a result, the
diversity of structures that can be efficiently explored and produced in medicinal chemistry research is relatively
limited. Existing methods suffer from several limitations: 1) reliance on non-selective synthesis routes, which
require additional resolution steps, thus limiting the efficiency of these approaches and 2) the predominant use of
electrophilic P(V) substrates that required pre-activation steps to install an appropriately reactive leaving group.
Catalytic cross coupling approaches to access P-chiral compounds currently have relatively narrow product scopes
and often rely on expensive transition metal catalysts that must be removed assiduously before biological testing.
An attractive new approach would be an organocatalytic asymmetric phosphonium dealkylation reaction that
generates P-chiral stereogenic centers by coupling P(III) nucleophiles and electrophilic activating agents. This
approach would address the previously mentioned key limitations while enabling chemists to catalytically and
selectively control the wide range of powerful reactions know to proceed through phosphonium species.
Hydrogen-bond donor (HBD) organocatalysts are known to catalyze the formation of ionic species by anion
binding while also controlling the stereochemical outcome of nucleophilic trapping of these species. By leveraging
the powerful transition state stabilization and synergistic dual nucleophilic and electrophilic activation capabilities
unique to HBD catalysts, this approach should enable phosphonium desymmetrization to be accomplished with
exquisite enantioselectivity.
The goal of this proposal is to design an anion pair binding organocatalyst to promote the first catalytic
enantioselective phosphonium dealkylation reaction capable of producing P-chiral products. The research plan
outlines a strategy to develop such a catalyst system guided by hypothesis-driven experimentation, computational
modeling, and structure-activity studies. To add to the information gained in the reaction development, a detailed
mechanistic study of HBD organocatalyst activation of simple phosphorus (III) substrates such as phosphonites and
phosphites will be undertaken using data-intensive multi-dimensional correlation. This study will enable simple
reagents to be utilized to produce medicinally relevant enantioenriched compounds in a novel manner, contributing
enormously to medicinal research, catalyst development, and substantially contributing to scientific knowledge.

Public health relevance
Project Narrative The proposed research is aimed toward the development of a new organocatalytic reaction that leverages networks of synergistic attractive interactions to rapidly and mildly transform inexpensive starting materials into valuable stereochemically defined products. The proposed strategy will allow preparation and biological study of new structures that were previously inaccessible or prohibitively difficult to synthesize. Ultimately, the proposed research will facilitate the exploration of new chemical structures in pharmaceutical research, and contribute to a greater understanding of new activation modes in small molecules catalysis.